CLINICAL TRIAL: EXTRARENAL 1-ALPHA-HYDROXYLASE IN END-STAGE RENAL DISEASE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The purpose of this study is to determine the effects of dietary vitamin D on the fundtion of white blood cells in patients with end-stage kidney failure who are requiring dialysis.